Open Source Hearing Assessment System for Open Science

PROJECT SUMMARY/ABSTRACT
The goal of this project is to build and validate an open-source research platform that will enable multiple-
measure diagnostic hearing research across human and animal species. Our proposed innovation will promote
reproducibility with easily connected open data repositories and accessibility to both researchers and subject
populations, ensuring that studies enroll large enough populations to achieve the statistical power the hearing
science community requires. Our user-friendly, low-cost, extendable, and mobile auditory test platform will
facilitate collaborative development and the open exchange of new datasets and measurement paradigms within
the broader hearing research community worldwide, including academia and industry. This project will leverage
Creare's existing open-source Audio Processing platform, Tympan, an open, published design device that uses
readily available components. The project will expand Tympan's functionality in fundamental ways: (i) it will
significantly enhance the scope by supporting transducers for common tests of auditory function, including
audiometry, otoacoustic emissions (OAEs), wideband acoustic immittance (WAI), speech recognition, and
eventually evoked potentials; (ii) it will add software designed to easily administer a test battery and share test
paradigms and data across research studies; and (iii) it will provide interfaces to back-end servers for seamless
storage in semantically enriched open science data repositories. The project promises significant
advances: (1) increased clinical transition of multiple-measure diagnostics through the open access to a
validated powerful research platform; (2) improved transparency, reproducibility, and standardization of human
and animal studies by providing easy access to an open science repository; and (3) increased access to
high-quality research tools for resource-limited laboratories that will expand the reach of hearing research.

Public health relevance
PROJECT NARRATIVE One in eight people in the United States aged 12 years or older has hearing loss in both ears, with varied root causes. This project will result in a new research platform that is completely open and accessible to anyone to conduct research studies (designs and source code will be openly available on the web). It will also allow researchers to store their data in an online hub that can be accessed by anyone to use and review the data. The ultimate objective is to spur innovation in the development of treatments and interventions for hearing loss.